Three-dimensional One-step Aptamer Selection in the Non-fouling Macroporous Hydrogel

Project Summary
Nucleic acid aptamers (aptamers) have been used as therapeutic agents or delivery ligands for various
biomedical applications such as regenerative medicine, cancer therapy, molecular biosensing, cell delivery,
detoxification, anti-inflammation, anti-coagulation, etc. However, the success of these applications largely
depends on the discovery and delivery of high-affinity and high-specificity aptamers, which remains challenging
today. Therefore, the objective of this project is to study an innovative method for aptamer selection and
truncation, and to further examine the efficiency of in vivo aptamer delivery in regulating inflammation. We will
work on four specific aims to achieve the objective. In the first three aims, we will focus on aptamer selection
and truncation. Notably, while these three aims are related to one another, the proposed research activities in
these aims can be conducted independently. After the selection and truncation of high-quality aptamers, we will
examine microneedle-mediated aptamer delivery for local, defined treatment of inflammation using an animal
model. The success of this project will not only lead to the development of a technological platform for
therapeutic aptamer discovery, but also pave a new way of fighting against inflammatory cytokines in the
treatment of complicated immune disorders.

Public health relevance
Project Narrative A novel platform will be studied for therapeutic nucleic acid aptamer discovery and delivery. Its success will lead to a paradigm shift in the development of therapeutic nucleic acids for the treatment of various human diseases such as immune disorders.